Statistical Methods for Data Integration and Applications to Genome-wide Association Studies

Abstract
Large-scale epidemiologic studies, including biobanks and genome-wide association studies
(GWAS), are now rapidly leading to the identification of novel risk factors for complex diseases.
There is now increasing opportunity to develop comprehensive models for disease risk
incorporating genetic markers, other biomarkers, life-style factors and sociodemographic
indicators. There are, however, major challenges as information on all of the potential risk
factors are often not available in a single adequately large study. Instead, information may be
available from different studies, each of which may include some subsets of the desired
variables. Further, because of logistical and privacy concerns with individual level data, only
summary-level information, i.e., estimates of model parameters, may be available from some
studies. We propose to develop a series of novel statistical methods that will allow data
integration across disparate datasets to tackle modern problems faced in genetics and more
broadly, observational epidemiologic studies. In Aim 1, we will develop a general framework for
building logistic regression models using detail covariate data from a main study, while
incorporating summary-statistics information from an external study. We will develop a series of
applications of this framework to GWAS where we will use covariate data, including high-
throughput biomarkers, from biobanks and perform combined analysis with external summary-
statistics data for powerful exploration of effect modification and mediation of genetic
associations by covariates. In Aim 2, we will extend the proposed framework of Aim 1 for
developing models with high-dimensional covariates with regularized parameter estimates. We
will develop application of the proposed method for fine-mapping and polygenic risk score
analysis conditional on covariates. In Aim 3, we will further develop multiple novel applications
of the data integration framework to account for different accuracy/depth of disease outcome
data across different studies. We will illustrate application of the proposed methods for risk
modeling of multiple cancers (breast, melanoma and lung), two cardiometabolic traits (type-2
diabetes and coronary artery disease) and a psychiatric disorder (major depression disorder)
using individual level data from the UK Biobank study and Breast Cancer Association
Consortium, and external GWAS summary-statistics. We will distribute develop and freely
distribute user friendly software.

Public health relevance
Narrative Novel statistical methods will be developed for integrated analysis of studies with disparate data structure, such as individual-level data from a main study and summary-statistics data from genome-wide association studies. Applications will lead to understanding of mediation and effect modification of genetic associations by environmental factors and biomarkers, development of polygenic risk scores suitable to be used with other risk factors, and powerful discovery of genetic associations for complex diseases combining different depth of phenotype data across different studies. User friendly and computationally efficient software will be developed and freely distributed.